Determining the clinical impact of gene expression testing in localized prostate cancer

The long-term goal of this project is to simultaneously decrease treatment-related morbidity from unnecessary
over-treatment of men with localized prostate cancer (PCa) while curing more men by minimizing under-
treatment of men with higher risk PCa. In this proposal we aim to determine if tissue based gene expression
classifiers (GEC) can be utilized to improve both cancer control and quality of life (QOL) in men with localized
PCa. This goal will be carried out through three specific aims. In Aim 1 we will develop a universal risk score
that combines genetic, clinical, and pathologic variables in a manner that is agnostic to which of the three
commercially available GEC tests used. This will be done through assembling a large cohort of men with
targeted MRI/ultrasound fusion biopsies of the same prostate tumor focus and analyzing individual tumors with
each of the three tests. We will then develop a conversion method aligning each GEC score with a new
universal score, and we will apply this to a cohort of 1000 men with newly diagnosed prostate cancer followed
in our statewide prospective registry. This data will be utilized to validate our recently developed clinical-
genomic risk grouping system, broadening it to incorporate all GEC tests, and focusing it on appropriate
stratification of favorable risk prostate cancer potentially suitable for active surveillance. We hypothesize that
the universal integrated clinical-genomic risk groups will provide improved discrimination compared to standard
clinical categories and will expand the pool of active surveillance-eligible patients. In Aim 2 we will conduct the
first ever prospective randomized trial of the clinical utility and clinical impact of GEC testing in favorable risk
localized prostate cancer, leveraging two statewide collaboratives containing over 60 urology and radiation
oncology practices. Patients will be randomized to standard clinical risk stratification +/- GEC testing in order to
determine the impact of testing on treatment decisions (active surveillance versus radical treatment), cancer
control, and QOL. We hypothesize that GEC testing will decrease the use of primary therapy and increase
QOL at 3 years, while maintaining rates of grade reclassification and biochemical recurrence at the same time
point. Aim 3 seeks to determine the clinical impact of GEC testing on treatment failure and patient-reported
QOL in men at high risk of recurrence post-prostatectomy. This aim leverages the recently accrued G-MINOR
trial that randomized approximately 350 men at high risk of failure after prostatectomy to clinical risk
stratification +/- GEC testing to assess decision making based on GEC testing. By extending the follow-up of
this trial, we will determine how GEC testing impacts long-term tumor control and QOL. We hypothesize that
GEC use in higher risk patients will provide more accurate risk stratification and targeted treatment decisions,
leading to improved cancer control and QOL. This work has the potential to personalize treatment decision-
making for PCa patients based on their tumor’s biology, allowing some men to avoid costly and toxic over-
treatment while also decreasing the burden of recurrent disease from inappropriate under-treatment.

Public health relevance
Narrative Tissue-based gene expression classifiers (GECs) are being increasingly utilized for men with localized prostate cancer to enhance the discriminatory power of standard clinicopathologic models and improve patient risk stratification. However, there remains a lack of evidence to support the widespread implementation of any of the GECs in clinical practice, with no prospective data demonstrating clinical utility or clinical impact of GEC testing on patient outcomes such as tumor control and quality of life. This work will produce a method to compare and implement risk thresholds across multiple GECs simultaneously, test the clinical utility and clinical impact of GEC testing in a new randomized trial of men with favorable risk prostate cancer, and perform long-term follow-up of the first ever randomized trial of GEC testing after radical prostatectomy (G- MINOR trial) to comprehensively determine the clinical impact of GEC use in localized prostate cancer.